NCI Community Oncology Research Program (NCORP) Disparities Integration Working Group Support

Support to the NCI by Scientific Consulting Group for NCI Community Oncology Research Program (NCORP) Disparities Integration Working Group Support